MOLECULAR GENETICS OF INHERITED NEUROLOGIC AND PSYCHIATRIC DISORDERS

We approached the characterization of the mutations responsible for inherited neurological or psychiatric disorders by studying the gene organization of specific proteins that might have a role in the pathogenesis of the clinical manifestations. Using the inherited lysosomal storage disorders, Gaucher disease and Fabry disease, as models, we demonstrated that the phenotypic heterogeneity seen within these inherited disorders is a consequence of different mutations, each affecting protein activity and influencing the processing, compartmentalization and/or stability of the protein. Similar approaches are being used to investigate the involvement of genes of chromosome II in mania-depression and other psychiatric disorders. Recombinant DNA techniques have been used to elucidate the structure of the gene for the proteins (enzymes and receptors) involved in these and other neuropsychiatric disorders. Restriction fragment length polymorphisms (RFLPs) have been identified that are useful for the identification of mutations in Gaucher disease that frequently occur in both non-neuronopathic and neuronopathic phenotypes. Northern blot analysis provides further details of the structure of the normal and mutant genes. The molecular mechanisms leading to nervous system involvement in these disorders have also been investigated. The results of this research should provide a more rational foundation for the diagnosis and formulation of therapeutic strategies for these inherited disorders. Genes on chromosome 11 specific for neurotransmitter biosynthesis have been isolated (for example, human tyrosine hydroxylase and tryptophan hydroxylase). Comparison of normal gene sequence to the gene sequence in Amish manic-depressive patients is in progress. Recombinant DNA approaches have been used to produce large amounts of tyrosine hydroxylase isozyme for structural and biochemical studies.